Mechanisms of experience dependent plasticity in mouse visual cortex

PROJECT SUMMARY
Visual experience plays an important role in shaping the functional organization of the primary visual
cortex (V1), both during development and in the mature animal. In adult mice, repeated exposure to a neutral
visual stimulus induces long-term adaptation of the evoked sensory response. However, whether this
phenomenon also occurs when the stimulus acquires behavioral salience is unknown. In addition, the underlying
mechanisms of this form of plasticity are similarly unclear. To address this question, we combine in vivo 2-
photon imaging of neuronal activity and glutamatergic signaling with behavioral training and virally-induced
genetic manipulation to monitor visually-evoked responses longitudinally across adaptation under different
experimental conditions. We will quantify how adaptation shapes the tuning of single neurons to specific features
of the visual input and determine whether association of the stimulus with reward alters both synaptic and cellular
plasticity during repeated stimulus delivery. Finally, we will identify the role of NMDA-type glutamate receptors
in experience-dependent adaptation and synaptic plasticity in vivo. Our results will provide critical new insight
into the relationship between sensory experience, synaptic plasticity, and visual representations in the neocortex.

Public health relevance
PROJECT NARRATIVE Pyramidal neurons in the primary visual cortex (V1) undergo a form of experience-dependent plasticity termed adaptation during repeated sensory stimulation. This proposal will explore the cellular and synaptic mechanisms of adaptation and its sensitivity to the behavioral valence of the visual input. These results will generate novel insights into the relationship between synaptic plasticity and sensory representations in the neocortex.